Center for Innovative NeuroTech Advancement (CINTA) - Resource Core

As the Resource Subawards Core, VentureWell will leverage their more than 25 years of experience and network of providers in supporting CINTA innovators through providing technical support in the fields of medical device commercialization and biomedical engineering. For CINTA, VentureWell will expand the partnership with CIMIT that was developed as part of the RADx Tech initiative by providing expert consultants, vendors, and service providers tailored to supporting neuro medical devices. The Resource Core will manage a roster of service providers, vendors, and individuals that can assist CINTA in providing support for selected projects and will provide administrative and programmatic oversight for all resource subawards. VentureWell will maintain a Qualified Resource Database, a database of experts, vendors, and service providers that includes verified expertise as well as availability, timeline to engagement, and expected rates for CINTA projects. As needs are identified by the Deep Dive teams, the Resource Subawards Core will work to develop a relevant scope of work and assess potential resources, both from the existing roster of resources and via solicitation of new or competitive resources. Once a resource is matched to an innovator subproject, the scope of work will be reviewed and confirmed by the Evaluation Core. Requests for resource support, whether for individual consultant or vendors, will be managed via similar processes as in the RADx Tech program; these processes have been streamlined based on lessons learned from RADx Tech. Specifically, both individual consultants and vendors will develop a scope of work with associated budgets, timelines, and deliverables, and once linked to an innovator subproject and awarded, they will be managed to deliverables and milestones by the Resource Subawards Core, in collaboration with the Mentor teams. Managing individual consultants and vendors/service providers through the same process will maximize efficiency and streamline project management and reporting.